Stability and Robustness of Hippocampal Representations of Space

PROJECT SUMMARY
How does the brain balance the need to preserve prior knowledge with the necessity to continuously learn
new information? The tradeoﬀ between stability and plasticity is inherent in both biological and artiﬁcial
learning systems constrained by ﬁnite resources and capacity. The hippocampus is a brain region critical for
memory formation and spatial learning, which can provide a powerful experimental system for characterizing
this tradeoﬀ. The role of the hippocampus in spatial cognition is supported by the ﬁnding that pyramidal
neurons in this area (place cells) ﬁre in speciﬁc locations in an environment (place ﬁelds). The population of
place cells active in an environment is believed to form a neural representation or cognitive map of that
environment. Spatial learning is critical for survival and involves two competing constraints: representations of
space must be plastic to enable fast learning of new environments and changes in behavioral contingencies,
and stable over time to enable recognition of familiar environments, reliable navigation, and leveraging of
previous learning. How do these competing constraints aﬀect the stability of place ﬁelds across time? The
experimental characterization of the long-term stability of spatial representations in the hippocampus has
been challenging as it requires tracking the activity of multiple place cells across extended periods of time
(days to weeks). We propose to use novel approaches in large-scale electrophysiology and imaging in
behaving rodents to characterize which neurons change their spatial tuning and how these changes depend
on behavior. Furthermore, we will use recordings and circuit perturbations to characterize the activity patterns
that predict changes in tuning stability. Our analysis will be carried out in the context of a theoretical
framework for understanding the interplay between plasticity and stability of hippocampal representations.
Characterizing the evolution of neural representations is of fundamental importance in understanding how
information is maintained across brain circuits and how such maintenance is perturbed in brain disorders.

Public health relevance
PROJECT NARRATIVE This project focuses on understanding how brain circuits critical for memory formation balance the need to preserve prior knowledge with the necessity to continuously learn new information. The balance between stability and plasticity may be disrupted in aging and in brain disorders such as Alzheimer's disease, and this project will provide a quantitative basis for studying such imbalance and its consequences.